Defining Evolutionary Trajectories: Molecular adaptation to antibiotic resistance

Antibiotic resistance among bacterial pathogens remains one of the great challenges confronting public
health in the world today. The widespread use of antibiotics has facilitated the rise of multi-drug resistant
pathogens that threaten to undermine the remarkable success of modern medicine. The Centers for
Disease Control and Prevention have identified multi-drug resistant enterococci as a “Serious Threat”
requiring prompt and sustained activity to limit proliferation. Daptomycin is a frontline antibiotic with
efficacy against Gram positive organisms and is used with increasing frequency against multi-drug
resistant enterococci such as vancomycin-resistant enterococci (VREs). The goal of this proposal is to
comprehensively map the evolutionary trajectories leading to DAP resistance in Enterococcus faecium
and elucidate how the identified changes in protein structure-function establish the physicochemical
basis for the observed resistance phenotypes. We use quantitative experimental evolution in a novel,
continuous culture bioreactor system to identify and rank the most important evolutionary trajectories
leading to resistance. Based upon these results, we then characterize the most relevant proteins and
pathways to daptomycin resistance using a combination of biochemical and structural approaches that
link the change in biophysical properties to resistance. Techniques include X-ray crystallography,
enzyme activity, ligand affinity, protein stability studies, RNAseq, qPCR, and others. This approach
seeks to determine, not only the biochemical basis for resistance, but also those candidate proteins
and pathways that would be well suited for the development of a new class of co-drugs that would
target and delay the development of resistance. Our studies can also provide valuable molecular
indicators of emerging resistance. Using our expertise in experimental evolution, we have also
developed a new approach to harness both the power of evolution and the largely unexplored
biochemical diversity and killing strategies of one of Nature's best antibiotic producing organisms:
Streptomyces. We use experimental evolution within micro-emulsion droplets to produce selection
conditions to identify variants of S. roseosporus (the “Predator”) that have improved their ability to kill
a VRE strain (the “Prey”). Within each micro-droplet, we trap the two populations (Predator and a Prey).
If the Predator can adapt to kill the Prey, the adapted Predator has a significant resource advantage,
and increased reproductive success, over the un-adapted Predator. Taken together, this project takes
a multi-pronged approach to uncovering the mechanisms and physicochemical basis for the evolution
of antibiotic resistance and extends experimental evolution to include a novel method for discovering
new antimicrobials.

Public health relevance
With multi-drug resistant bacteria becoming increasingly common in hospitals, antibiotic resistance has threatened to return us to a pre-antibiotic era that would completely undermine modern medicine. There is an urgent need to develop new antibiotics and strategies to combat resistance that are substantially different from earlier drug discovery efforts. We are using quantitative experimental evolution to identify the evolutionary trajectories to multidrug resistance in pathogens and developing new technologies that can identify novel strategies and potentially new antibiotics for killing vancomycin-resistant enterococci.